Identifying social computational phenotypes in mental health

PROJECT SUMMARY
The ability to learn about other people and make social decisions is critical for successfully navigating our
complex social environment and the consequences of failure can be severe (e.g., loss of employment, damage
to relationships, etc.). Impairment in the social processes that support this ability is a key component of
dysfunction across many mental health disorders. However, there has been a lack of systematic, data-driven
research on the relationship between socio-cognitive impairment and mental illness. Moreover, what research
exists has been limited in the social processes it surveys, disorder-focused, and population-specific, in contrast
to efforts to reconstrue mental health within a multidimensional set of transdiagnostic spectra (e.g., the NIMH
research domain criteria; RDoC, and the Hierarchical Taxonomy of Psychopathology; HiTOP). Computational
Psychiatry has had great success using computational approaches to decompose behavioral indicators of mental
disorder into their component processes and identify computational phenotypes. However, this research has
focused primarily on nonsocial learning and decision-making computations. A critical next step is the systematic
data-driven exploration of how mental health spectra map onto social computational phenotypes.
Using large-scale data-driven approaches in combination with behavioral, computational, psychological
assessment, and neuroimaging (fMRI) methods in healthy adults (ages 18-35), we will systematically investigate
the social-cognitive aspects of individual differences in mental health with the goal of identifying social
computational phenotypes (SCPs) that correspond to distinct transdiagnostic mental health spectra. Across two
aims, participants will complete a battery of learning and decision-making tasks assessing three levels of learning
(nonsocial learning, trait learning (i.e., social with no Theory-of-Mind; ToM), and ToM learning), and three
feedback types (informational, monetary, social), two dimensions of great relevance to mental health. We will
also quantify individual variation along multiple transdiagnostic mental health spectra using the HiTOP.
Employing a rigorous data-driven approach, we will first conduct a large-scale (N=1000) online exploratory study
to identify mental health-related SCPs (Aim 1a). We then will conduct a confirmatory study (N=500) in which we
target the three most robust SCPs identified in Aim 1a, assessing replicability and quantifying out-of-sample
predictive power (Aim 1b). Finally, we will adapt our task design for model-based fMRI (N=55; Aim 2) to probe
the neural correlates of the single-most most robust SCP identified in Aim 1b. The results of this work will provide
a much-needed foundation for understanding the relationship between social learning and decision-making and
mental health, as well as insights into the etiology of psychopathology, and novel targets for treatment.
Importantly, this project will provide cutting-edge interdisciplinary training in behavioral, computational, and
neuroimaging methods for undergraduates in the PI’s laboratory, fulfilling the goals of the R15 mechanism.

Public health relevance
PROJECT NARRATIVE The ability to learn about other people and hold a representation of them in our mind is critical for successful navigation of our social environment and the consequences of failure can be severe (e.g., loss of employment, damage to relationships, etc.). Specialized neural systems may support these social-cognitive processes and their impairment is characteristic of many mental health disorders, however, there is a lack of programmatic research on the social-cognitive aspects of mental disorder. This project will use large-scale data-driven approaches in combination with behavioral, computational, psychological assessment (HiTOP), and neuroimaging (fMRI) methods to systematically probe the social-cognitive aspects of individual variation in mental health with the goal of identifying social computational phenotypes that can better inform future research and treatment of a broad range of psychopathologies.